From intra to intercellular regulatory networks that define cell type identity

Project Abstract
Cell fate engineering, for example the directed differentiation of pluripotent stem cells, holds great promise for
disease modeling, drug screening, and regenerative medicine. However, our ability to engineering cell fate with
fidelity has been impeded by an incomplete understanding of inter- and intracellular networks that govern
differentiation, and by the lack of adequate computational tools to distill testable hypothesis from the mountains
of data coming from single cell omics technologies. In the parent award of this grant, we are addressing the
following unanswered questions and unmet challenges that emerged from our prior work. First, we are
extending our computational methods that assess the outcomes of cell fate engineering to more data types,
thus increasing the comprehensiveness of their results. Second, we are substantially improving and extending
our regulatory network tools so that they are statistically calibrated and so that they can ingest chromatin
accessibility and expression data simultaneously to discover binding site motifs of orphan transcription factors.
Third, we are devising computational methods to generate reliable cell fate engineering recipes that account
for not only transcriptional networks but also how signaling pathways inform them, and that account for
temporal dynamics. The Imaging system that we are requesting in this supplement grant is crucial for us to
experimentally assess the predictions that emerge from our computational algorithms to improve the directed
differentiation of pluripotent stem cells to, first, mesoderm sub-types, and second, to articular chondrocytes.
Meeting these goals will shed light on how signaling pathways and intracellular regulatory networks interact
during differentiation, and it will help to make cell fate engineering more reliable and controllable.

Public health relevance
Project Narrative Cell fate engineering, for example the directed differentiation of pluripotent stem cells or the direct conversion among somatic cell types, holds great promise to improve disease modeling, drug screening, and to lead to regenerative medicine therapies. However, our ability to engineering cell fate with fidelity has been impeded by an incomplete understanding of the biological networks that govern development. In the parent award for this grant, we are addressing this problem through a combination of algorithm development and experimental validation, with an emphasis on cell types related to the synovial joint, as well as their developmental progenitors. The Imaging System that we request in this grant will transform our ability to address the overarching goals of the parent award by enabling us to perform more rigorous, robust, and quantitative imaging of our validation and discovery experiments.